Maturation of frontal cortico-thalamic circuitry in control of social behavior

Impaired social processing is one of key hallmarks of many neurodevelopmental and psychiatric disorders
including autism spectrum disorders (ASDs). As the social deficits tend to emerge during early childhood and
adolescence, characterization of developmental trajectories is vastly important for understanding and treating
underlying disruptions. The objective of our study is to identify the developmental mechanisms and windows
when circuits responsible for social processing are sensitive to modulation by aberrant social experience or
genetic risk of disorders. Such information will point toward therapeutic targets that allow amelioration of social
deficits. During the prior funding period, we demonstrated that corticothalamic projections from medial prefrontal
cortex (mPFC) to paraventricular nucleus of thalamus (PVT) (mPFC->PVT), which relays signals to various
components of the classical reward circuitry, is causally necessary for proper sociability, but is dysregulated by
juvenile social isolation in adult mice. Our preliminary study further revealed that mPFC->PVT neurons are also
dysregulated by the deletion of several ASD related genes including Fmr1. These findings prompt new pressing
questions: When and how the circuit and behavior deficits emerge across development? Can these vulnerability
windows serve as windows for preventing sociability deficits? Even if these windows are missed, to what extent
adult amelioration is possible later in life? In this competitive renewal, we propose to address these questions
by testing a hypothesis that juvenile social isolation or genetic risk of ASD (Fmr1 deletion) convergingly
dysregulates the maturation of mPFC->PVT projection neurons and sociability yet differentially impact the circuit
at different developmental windows. We will also test that these developmental windows of vulnerability also
serve as windows for interventions to prevent sociability deficits, while adult reversal is also possible by circuit-
based interventions. We will test this hypothesis by integrating techniques to measure (fiber photometry imaging,
patch-clamp/ in vivo electrophysiology) and manipulate (optogenetics/chemogenetics) the activities of selective
circuits during social behavior in male/female mice.

Public health relevance
This study aims to identify the developmental mechanisms and windows when a frontal circuit projecting to thalamus, which is responsible for social processing, are sensitive to modulation by aberrant social experience or genetic risk of neurodevelopmental disorders. Such information will point toward therapeutic targets that allow amelioration of social deficits.